Effects of Low Carbohydrate and Low Fat Diets on Endothelium Function in Obesity

DESCRIPTION (provided by applicant): Obesity is a risk factor for atherosclerosis and is a major cause of morbidity and mortality in the United States. Endothelium derived nitric oxide (NO) a key regulator of arterial homeostasis is lost in the early stages of atherosclerosis. Reduced NO bioavailability during obesity involves increased generation of reactive oxygen species (ROS) that scavenge NO. Most studies indicate that diet induced weight loss, the cornerstone of weight management strategies, improves endothelial function. The benefits of the recently popularized low carbohydrate (LC), Atkins' diet, on endothelial health are controversial since they require strict reductions of carbohydrate intake at the expense of high dietary fat content. For instance, a recent study in our laboratory showed divergent effects of isocaloric LC and low fat (LF) diets on NO- mediated endothelium- dependent flow mediated dilation (FMD). While FMD was improved on a LF diet, it was impaired on a LC diet suggesting that the potential benefits of weight loss on NO are negated on LC. The overall hypothesis of this study is that low carbohydrate diets reduce the benefits of weight loss on endothelial function by lowering the protective effect of adiponectin against endothelial reactive oxygen species generation compared to isocaloric low fat diets. Thus, LC diets impair NO- mediated endothelium-dependent dilation of isolated peripheral resistance arteries. This hypothesis is supported by preliminary data indicating adiponectin is reduced and resistance artery endothelial function is impaired on LC diets. This will be tested with a prospective, randomized, 6 week feeding trial in obese (BMI: 30- 39) subjects ages 18-40. Low fat or Low carbohydrate diets will be administered at caloric thresholds designed to either lose or maintain weight in each group. Endothelial- dependent vasodilation will be determined in isolated resistance arteries obtained from subcutaneous fat biopsies before and after 6 weeks of dietary intervention. In aim 1 we will determine the contribution of endothelial oxidant systems on reduced NO- mediated endothelial function in resistance arteries during low carbohydrate diets compared to isocaloric low fat diets. In aim 2 we will determine whether low carbohydrate diets increase pro-atherogenic adipokines, decrease anti-atherogenic adipokines, or both. In aim 3 we will test whether adiponectin improves endothelial function in resistance arteries of subjects on low carbohydrate diets and whether the mechanism involves eNOS regulation (phosphorylation) or superoxide dismutase expression. Pharmacologic inhibitors, fluorescent probes for ROS and NO, HPLC, and molecular approaches of measuring enzyme expression will determine the site and source of ROS and NO production in vascular tissue. Adipokine mediated endothelial dysfunction has been linked to high fat intake and if confirmed on a low carbohydrate diet will provide clinically important information regarding the mechanisms whereby diets differing in macronutrient contents can be optimized to improve vascular function during weight loss. These results will begin to address how lifestyle interventions that optimize adiponectin may be used to prevent the vascular risks associated with diets high in fat.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity is a risk factor for heart disease and a major cause of death and disability in the United States. A variety of weight loss strategies have gained attention including traditional Low Fat (LF) and the recently popularized Low Carbohydrate (LC) diets. The proposed feeding trial will examine the impact of 6 weeks of LF and LC diets designed for body weight loss and maintenance on vascular endothelial function (an early prognostic indicator of the propensity for heart disease) in young men and women. Project Narrative Obesity is a risk factor for heart disease and a major cause of death and disability in the United States. A variety of weight loss strategies have gained attention including traditional Low Fat (LF) and the recently popularized Low Carbohydrate (LC) diets. The proposed feeding trial will examine the impact of 6 weeks of LF and LC diets designed for body weight loss and maintenance on vascular endothelial function (an early prognostic indicator of the propensity for heart disease) in young men and women. __SpecificAimsTextDelimiter__ A. Specific Aims. Obesity is a major global health problem. The pathogenesis of obesity involves inflammation and impaired vascular endothelial function which contributes to cardiovascular disease. The traditional recommendation for a low-fat (LF), restricted calorie intake is associated with cardiovascular risk factor reduction. Low fat diets are generally believed to improve endothelial function6-9 since nitric oxide (NO)- dependent flow-mediated dilation (FMD) can increase after weight loss. An alternative diet, the low carbohydrate (LC) diet that calls for strict reduction of carbohydrates and liberal amounts of dietary fats has become popular in recent years with roughly one in eleven American adults embracing this recommendation10. However, the high fat intake on low carbohydrate stimulates nuclear transcription factor-κB (NF-κB)11, which upregulates the expression of pro- atherogenic adipokines (IL-6 and leptin) and reduces the anti- atherogenic adipokine adiponectin. This imbalance leads to the generation of reactive oxygen species (ROS) generation, reduced NO bioavailability, and endothelial dysfunction, thereby masking the full benefits of weight loss on cardiovascular risk. In a recent feeding trial, our laboratory showed that, despite similar weight loss and blood pressure lowering effects of isocaloric LC and LF diets, LC impaired FMD while LF improved it. This surprising divergence, evident at 6 weeks, suggests that macronutrients (fat) during LC diets obviate the benefits of weight loss on endothelium. Our goal is to investigate why weight reduction is not associated with improved endothelial function during a low carbohydrate diet in obese patients without cardiovascular risk factors. The overall hypothesis is that low carbohydrate diets reduce the benefits of weight loss on endothelial function by lowering the protective effect of adiponectin against endothelial reactive oxygen species generation compared to isocaloric low fat diets. Thus, LC diets impair NO- mediated endothelium-dependent dilation of isolated peripheral resistance arteries. We propose a randomized 6 week feeding trial with 4 groups of LC and LF diets provided at restricted calorie levels for weight loss (4 weeks weight loss and 2 weeks of body weight stabilization) or for weight maintenance (no body weight changes for 6 weeks). Aim 1: To determine the contribution of endothelial oxidant systems on reduced NO- mediated endothelial function in resistance arteries during low carbohydrate diets compared to isocaloric low fat diets. This aim will also test the hypothesis that NO- mediated endothelial function is further impaired in subjects given a low carbohydrate diet for weight maintenance compared to those given the same diet for weight loss. Vascular wall accumulation of NO and ROS will be measured to test the following hypotheses 1a. Low carbohydrate weight maintenance diets show greater impairments in resistance artery endothelial function compared to low carbohydrate weight loss and isocaloric low fat diets; 1b. Generation of ROS by the microvascular endothelium is greater during weight maintenance than weight loss groups on low carbohydrate diets, and both exceed ROS production during isocaloric low fat diets. The mechanism involves increased expression of enzymes responsible for ROS during obesity and high fat (xanthine oxidase and NADPH oxidase). Aim 2: To determine whether low carbohydrate diets increase pro-atherogenic adipokines, decrease anti-atherogenic adipokines, or both. We anticipate that both an increase in pro-atherosclerotic signaling and an increase in ROS will occur on low carbohydrate but not low fat diets. This will result in reduced microvascular NO generation and endothelial dysfunction on LC diets. These hypotheses will be tested: 2a. Low carbohydrate diets augment the expression of NF-κB and pro-atherogenic adipokines (leptin, TNF-α, and IL-6) while reducing anti-atherogenic adipokines (adiponectin) compared to low fat diets. 2b. Resistance arteries from subjects on low fat, but not low carbohydrate diets, are protected against acute ROS stimulated by pro-atherogenic adipokines (leptin, TNF-α, IL-6)- and low density lipoproteins. Aim 3: To test whether adiponectin improves endothelial function in resistance arteries of subjects on low carbohydrate diets and whether the mechanism involves eNOS regulation (phosphorylation) or SOD expression. Enzyme expression (eNOS and SOD) and endothelial function will be determined in isolated resistance arteries from subjects in each group. Pioglitazone, a thialzolidinedione that stimulates adiponectin release from subcutaneous fat12, will be used as an alternate physiological means to determine if adiponectin released from fat of LC dieters phosphorylates eNOS at sites that increase NO. Further confirmation of eNOS and antioxidant enzymes will be made with laser capture micro dissection. We anticipate an increased NO production and reduced ROS generation during LF vs. LC dieting. The following hypotheses will be tested: 3a. Expression of eNOS and antioxidant enzymes (SOD and catalase) are reduced in patients on low carbohydrate compared to isocaloric low fat diets. 3b. Adiponectin reverses endothelial dysfunction in response to a low carbohydrate diet, by phosphorylation of eNOS, quenching of ROS, and enhanced SOD expression, resulting in an increase in NO production. Exogenous adiponectin and pioglitazone-stimulated adiponectin from perivascular fat will be used to interrogate eNOS phosphorylation and expression. If pioglitazone reverses impaired NO production and resistance artery function in the presence of perivascular fat, this aim will begin to delineate the precise mechanisms whereby adiponectin restores vascular function during low carbohydrate and provide new rationale for therapeutic intervention for obesity. New preliminary data showing impaired endothelial function in resistance arteries on LC diets and lower adiponectin on LC but not LF diets support the hypothesis. Adipokine mediated endothelial dysfunction has been linked to high fat diet and, if confirmed on a low carbohydrate diet will provide clinically important information regarding the physiological mechanisms whereby diets differing in macronutrient contents can be optimized to improve vascular function during weight loss. These results will begin to address how lifestyle interventions that optimize adiponectin may be used to prevent the vascular risks (endothelial dysfunction) associated with diets high in fat.